DOSE STUDY OF HEMODYNAMICS OF FPL 63547XX IN CONGESTIVE HEART FAILURE

Assessment of safety and tolerability including first dose hypotension of single doses of the study drug in patients with class II-IV congestive heart failure. Evaluation of single dose pharmacokinetics and its correlation with hemodynamic response.